Elucidating the functions of novel enhancer elements in the Ig kappa locus

?DESCRIPTION (provided by applicant): The Igκ locus is responsible for the production of a large variety of Ig light chain rearrangements, but how these processes are regulated is unknown. The generation of a diverse Igκ repertoire is facilitated by contraction of the locus at the time of Igκ rearrangements. These changes in the 3-dimensional structure of the Igκ locus brings Vκ genes throughout the locus in closer proximity with the Jκ genes to which one Vκ gene will rearrange in each pre-B cell. However, the factors involved in orchestrating locus compaction and long-range looping interactions of the Igκ locus in pre-B cells are unknown. Also, it is not known how the 3D structure affects Vκ gene utilization. The Feeney lab has performed ChIP-seq in RAG-/-?+ pre-B cells and RAG-/- pro-B cells for a wide variety of histone modifications, including H3K4me1, the epigenetic marker of enhancer elements. Surprisingly, in addition to the three known enhancers at the 3' end of the Igκ locus, many H3K4me1 peaks were observed within the large Vκ part of the locus in pre-B cells, and most were not present in pro-B cells. This developmental stage-specificity of the H3K4me1 peaks suggests that these regions may play a role in regulating Vκ rearrangement. In addition, two published studies revealed regions within the Vκ locus that are preferential sites of long-range interactions with iEκ, the enhancer located just 2 kb downstream of the Jκ genes. Furthermore, the Feeney lab showed that the most predominant long-range interaction 'hubs' from those two studies are characterized by regions of high H3K4me1, and ChIP-seq data revealed that these 'hubs' bound multiple key transcription factors (TFs) such as Pax5, EBF, E2A, Ikaros, PU.1 or YY1. We therefore hypothesize that some of these novel enhancer-like elements are important in regulating the composition of the Igκ repertoire, possibly through orchestrating the 3D configuration of the compacted Igκ locus. To test this hypothesis, we will delete specific enhancer-like regions, and mutate individual TF binding sites within these regions, in an Abelson (Abl) pre-B cell line using CRISPR/Cas9 homologous recombination genome editing technology. Culture of the Abl pre-B cell lines with the Abl-kinase inhibitor STI571 for 48 hours robustly induces a diverse repertoire of Igκ rearrangements. We will assay the effects of the deletions or mutations on long-range interactions by 3C (chromosome conformation capture) and 4C. Changes in the Igκ repertoire will be assayed by TaqMan real time PCR and by deep sequencing on an Ion Torrent PGM. If our hypothesis is correct, then deletion of key TF binding sites and/or larger regulatory regions with binding sites for several key TFs will affect the long-range looping patterns within the Igκ locus, and will affect the resulting Igκ repertoire. We wil determine whether the effect of the deletion on the resulting Igκ repertoire will be predominantl on genes in the vicinity of each putative regulatory region or more globally. If we should observe any of these effects, this would demonstrate a highly novel function for these elements bearing the epigenetic characteristics of traditional enhancers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The establishment of a diverse repertoire of antibodies is essential for the proper functioning of the immune system to combat a wide variety of pathogens. Here we will study new regulatory elements that may orchestrate the V(D)J recombination process by which the light chain genes of antibodies are assembled. The large scale movement of the Ig loci during rearrangement places it in close proximity to other genes including oncogenes, and inappropriate regulation of the double-strand DNA breaks that occur during V(D)J recombination can then result in translocations of those oncogenes with Ig genes resulting in lymphomas and leukemias.